The Role of Glutamine Metabolism for P. gingivalis-Induced Non-Canonical Autophagy in Epithelial Cells

Growing evidence underlines that Glutamine (Gln) metabolism can influence key metabolic and autophagic
cellular events. Porphyromonas gingivalis (P.g) is a major periodontopathic, fastidious, pathobiont and
successful colonizer of gingival mucosa, which has recently been identified to induce a special form of
autophagy in human gingival epithelial cells (GECs). While GECs function as an intrinsically important first line
of immune defense of the gingiva, GECs can be exploited by P.g for securing a successful persistence niche in
the oral mucosa and a potential systemic dissemination route. Despite the growing evidence pinpointing that
altered Gln metabolism can contribute to cellular pathologies, knowledge gaps remain regarding how host Gln
metabolism could be influenced by bacteria to regulate host redox homeostasis and potentially promote
bacterial survival in the GECs. Recently, we discovered that P.g steadily increases robust Glutathione (GSH)
production in GECs to combat host-mediated oxidative stress-driven pathogen clearance. Our novel findings,
for the first time, show that P.g infection alters host Gln metabolism, a component of GSH synthesis, in GECs.
In addition, we recently demonstrated that P.g induces a pro-bacterial form of autophagy in GECs, where
Endoplasmic Reticulum-rich (ER)/Microtubule-associated protein 1A/1B-light chain 3 (LC3) double membrane
autophagosomes act as replicative niches for P.g and protect the bacteria from antimicrobial degradation
pathways. Our novel data shows that the biogenesis and maintenance of these P.g-containing
autophagosomes is dependent on the critical redox molecule, Glutathione Peroxidase 1 (GpX1). The
dependency on GpX1 can be markedly altered by increasing free Gln levels in GECs' cellular environment.
Thus, our overarching hypothesis for this proposal is that P.g alters host Gln metabolism in GECs to
maintain host redox homeostasis and specifically contributes to the biogenesis of a GpX1-driven, pro-bacterial
form of autophagy. Two Specific Aims are proposed to test this hypothesis. Aim 1 will characterize the
phenotypic molecular events occurring during P.g infection that specifically associate with host cell Gln
metabolism and the host cell redox state, allowing for the intracellular survival of P.g in GECs. Aim 2 will
mechanistically determine the molecular interactome involved in P.g-induced autophagy through the
modulation of host Gln metabolism in GECs. These collectively will identify what elements of the Gln metabolic
pathways are critical for the autophagic survival of P.g in GECs, and will elucidate the specific molecular
machineries involved in pro-bacterial autophagy driven by changes in host Gln metabolism upon P.g infection.
Overall, this proposal will contribute to the identification of novel targeted therapeutic strategies to control the
chronic intracellular colonization of P.g in the oral mucosa and beyond. Receiving the F31 Fellowship for this
proposal will further the applicant's research goals, critically contribute to her training in the field of Oral
Biology, and will foster her unique development as an oral health academic scientist.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to elucidate how the gum disease-causing microorganism, Porphyromonas gingivalis, can modulate specific gingival (gum) epithelial cell mechanisms to establish successful colonization inside the major barrier cells of the mouth. Our novel data reveals that P. gingivalis can specifically increase human gum epithelial cell's glutamine metabolism to suppress cellular oxidative stress and to induce a special variant of host cell autophagy that helps P. gingivalis' intracellular life in the gum cells. Thus, this study will elucidate the significance of the host epithelial glutamine regulation by P. gingivalis infection and the associated molecular machineries to define novel molecules/pathways that might be targets for devising new therapeutics for curtailing P. gingivalis' chronic presence in the gum epithelial cells.